Probing INTS11 as a novel target in neuroblastoma

PROJECT SUMMARY
Nearly a thousand children are diagnosed each year with Neuroblastoma (NBL) in the United States, and
this cancer is, by far, the most prevalent type in infants. Sadly, high-risk NBL, which comprises ~70% of
all NBL cases, has a five-year survival rate of <50%. High-risk NBL is characterized by having
amplification of the MYCN gene and deletion of the 1p36 (D1p36) region of chromosome one, which
houses multiple tumor suppressors. But these signatures are difficult to exploit as pharmacologic
inhibition of MYCN has proven elusive, and re-activating tumor suppressor gene expression after
genomic loss is virtually impossible. Consistent with MYCN’s established role in increasing global
transcription, high-risk NBLs with amplified MYCN expression are uniquely dependent on the cellular
transcription and RNA processing apparatus. Among this machinery vital to MYCN function is the
Integrator Complex, which is responsible for UsnRNA biosynthesis essential for co-transcriptional splicing
and promoting RNA polymerase II (RNAPII) turnover and plasticity. Integrator is a 14-membered complex
associated with RNAPII and is fundamental in regulating transcriptional output. My laboratory has been
investigating the molecular mechanism of Integrator for over ten years(19-34), and we have found that
Integrator subunit 11 (INTS11) is the critical enzymatic component of the complex. INTS11 utilizes its
RNA endonuclease activity to cleave the 3'-end of spliceosomal UsnRNA and is thus required for pre-
mRNA splicing. Moreover, we recently found that INTS11 is also necessary to cleave nascent protein-
coding RNA to promote RNAPII recycling. Both functions are critical to support high transcription
observed when MYCN is overproduced. Beyond being required in MYCN-amplified tumors, the most
attractive feature nominating Integrator as a potential druggable target in NBL is that the INTS11 gene is
located within 1p36 and is frequently deleted in NBLs. In support of this observation, data from DEPMAP
reveals that NBL cell lines are highly sensitive to partial depletion of INTS11, indicating a unique and
robust dependency on this gene. Altogether, these observations support a hypothesis that INTS11
represents a novel and unexplored target in NBL (Fig. 1), and our Specific Aims below are designed to
test this directly. Specific Aim 1. Determine the sensitivity of MYCN-amplified and D1p36 NBL cell lines
to INTS11 downregulation. Specific Aim 2. Test candidate inhibitors of INTS11 for differential toxicity in
high-risk NBL cell lines.

Public health relevance
Project Narrative High-risk neuroblastoma is characterized by amplifying the MYCN gene and deleting the 1p36 (D1p36) region of chromosome one, which houses multiple tumor suppressors. This proposal will test the hypothesis that the INTS11 protein is a potentially novel target in high-risk neuroblastoma. To that end, we will utilize a combination of INTS11 knockdown and small molecule inhibitors to determine if neuroblastoma cells are uniquely dependent on INTS11 for viability.